Enhancing Mississippi's Integrated Food Safety Program by Maintaining ISO 17025 Accreditation

The$ Food$ Safety$ Modernization$ Act$ allows$ the$ FDA$ to$ improve$ the$ food$ safety$ system$ and$ better$ protect$ the$ public.$ The$ Manufactured$ Food$ Regulatory$ Program$ Standards$ are$ a$ key$ component$ for$ the$ establishment$ of$ an$ integrated$ food$ safety$ system.$ These$ standards$ establish$ a$ basis$ for$ measuring$ and$ improving$ prevention,$ intervention,$ and$ response$ actions$ so$ federal$ and$ state$ agencies$ can$ work$ together$ more$ efficiently$ to$ reduce$ foodborne$ illness.$ In$ Mississippi,$ the$ Mississippi$ Department$ of$ Health$ regulates$ food$ products$ manufactured,$ held,$ and$ distributed$ within$ the$ State$ and$ the$ Mississippi$ State$ Chemical$ Laboratory$ serves$ as$ the$ official$ testing$ laboratory.$ Accreditation$ is$ necessary$ for$ a$ state$ and$ federal$ integrated$ food$ safety$ system.$ Therefore,$ we$ propose$ to$ maintain$ and$ augment$ our$ scope$ of$ ISO/IEC$ 17025$ accreditation,$ strengthen$ our$ collaboration$ with$ the$ MSDH,$ collect$ a$ minimum$ of$ 75$ samples$ to$ be$ analyzed$ for$ surveillance$ under$ the$ manufactured$ food$ regulatory$ program,$ and$ streamline$ our$ data$ upload$ to$ eLEXNET.$

Public health relevance
The$ Mississippi$ State$ Chemical$ Laboratory$ is$ a$ regulatory$ agency$ seeking$ to$ maintain$ and$ enhance$ their$ ISO/IEC$ 17025$ accreditation,$ strengthen$ the$ collaboration$ with$ the$ Mississippi$ Department$ of$ Health,$ collected$ and$ analyze$ a$ minimum$ of$ 75$ manufactured$ food$ samples$ for$ surveillance,$ as$ well$ as$ streamline$ data$ upload$ to$ the$ eLEXNET$ system.$ These$ objectives$ are$ key$ components$ for$ an$ integrated$food$safety$system.$ $